Optimization of novel thioesters as a therapeutic strategy for combating opioid overdoses and abuse

Abstract
The current opioid crisis in the US is fueled by the availability and extreme potency of the synthetic opioids
fentanyl, carfentanil and sufentanil. The major objective of this U-01 proposal is to optimize our lead thiolester
candidate, D-cysteine ethyl ester (JMS-19) as a viable therapeutic agent to elicit a rapid and sustained reversal
of opioid-induced respiratory depression (OIRD, a major cause of death) elicited by the potent synthetic opioids
fentanyl, sufentanil and carfentanil, without eliciting withdrawal symptoms in opioid-addicted subjects. This
work will involve a series of in silico, in vitro, ex vivo, and in vivo techniques that will first optimize the chemical
structure of JMS-19 (i.e., produce a derivative with greater efficacy and chemical stability) and then determine
the pharmacodynamics, pharmacokinetics, and safety for the lead compound, laying the groundwork for
seeking FDA approval for studies in humans. An example flow of drug development will be D-CYSee to D-
cysteine methyl ester (that we predict will be approximately 100 times more potent than D-CYSee) to S-nitroso
(SNO)-D-cysteine methyl ester (we have established that SNO-D-cysteine ethyl ester is approximately 1,000
times more potent than D-CYSee) to S-ethyl-D-cysteine methyl ester and S-sulfinic-D-cysteine methyl ester
(which we predict will be equally potent to the SNO-derivatives but much more chemically stable and resistant
to enzymatic degradation). We will provide compelling evidence that JMS-19 reverses OIRD without eliciting
any withdrawal symptoms in rats treated with morphine or fentanyl, and will provide key data, which strongly
suggest that the primary mechanism of action for JMS-19 and the related thiolesters is by binding to and
inactivating β-arrestins 1 and 2. These molecular key targets will allow us to optimize JMS-19 for maximum
efficacy in silico and in vitro, for ultimate testing against the opioids in freely-moving male and female rats. This
will combine molecular dynamics simulations which will optimize JMS-19's membrane permeability and binding
to active β-arrestins 1 and 2. These computational results will be confirmed experimentally by means of
hydrogen deuterium exchange mass spectrometry before the final pharmacodynamics data will be shared with
the rest of the project. The in vivo studies will involve (1) testing D-CYSee and optimized structural analogues
against fentanyl, carfentanil and sufentanil to determine in detail how out test thiolesters reverse the negative
effects of the opioid on ventilatory timing and mechanics and arterial blood-gas chemistry in freely-moving
male and female rats, and (2) combinations of fentanyl and methamphetamine, and often deadly (ventilatory-
depressant) combination in humans. Finally, we will perform pharmacokinetic studies on at least one of the
optimized D-CYSee derivatives to establish the temporal distribution of these compounds in the absence and
presence of fentanyl in order to relate the efficacy of the thiolesters with the pharmacological reversal of OIRD.
In summary, we are confident that our project will produce a series of active thiolesters with potent abilities to
elicit rapid and sustained reversal of the OIRD elicited by potent synthetic opioids.

Public health relevance
Project Narrative The opioid epidemic is a well-recognized threat to public health, and in this project we seek to address this crisis by optimizing our lead compound D-cysteine ethyl ester (JMS-19), and related thiolesters, as a novel therapy for reversing opioid induced respiratory depression without eliciting withdrawal symptoms in addicts. We will optimize JMS-19 for maximum efficacy and determine its pharmacodynamics, pharmacokinetics, and safety to prepare it for future clinical trials.